Project 4 - Characterizing and Overcoming Resistance to ERBB2 Directed Therapy in Metastatic Gastric and Esophageal Adenocarcinoma

Project Summary
ERBB2 is amplified in ~20% of Gastric and esophageal adenocarcinomas (GEAs) and
metastatic ERBB2+ GEAs are treated with a combination of chemotherapy and the antibody
Trastuzumab. However, Trastuzumab is only modestly effective in GEA, and all other targeted
agents in ERBB2+ breast cancer have failed in GEA clinical trials. We propose to directly
address the two primary factors that we hypothesize to mediate failure of ERBB2 therapy in
GEA: adaptive resistance and genetic complexity. To perform these studies, our team of
investigators with complementary skill sets will both perform detailed assessment of optimal
approaches to stably inhibit ERBB2 using an array of patient-derived model systems.
Furthermore, we will perform a prospective clinical collection spanning multiple large academic
medical centers in which we evaluate the genetic evolution of ERBB2+ GEAs during therapy,
define genetic alterations that accompany resistance and then functionally validate mechanisms
of resistance and optimal combination therapy. We will also explore the role of cell-free (cf)DNA
genomic profiling to guide therapy in the face of genomic evolution of the disease during
therapy. The overall goal will be to validate candidate resistance mechanisms and seek to
define optimal combination therapies that can overcome them. We therefore propose the
following Specific Aims: Aim 1: To define mechanisms of adaptive resistance to ERBB2
therapy in GEA patient samples and to develop optimal targeted combinations to stably inhibit
ERBB2 activity in GEA model systems. Aim 2: To evaluate genetic etiologies of resistance by
determining how frequently resistance results from ERBB2-negative subclones or from
secondary genomic alterations in ERBB2+ tumor cells. Aim 3: To validate mechanistically the
capacity of secondary genomic alterations to promote Trastuzumab resistance and to test
combination therapies to overcome resistance. In summary, we will define genetic and non-
genetic mechanisms of resistance to ERBB2 therapy. Ideally, our studies will lead to the
development of active/optimal candidate therapies that work well in first-line therapy as well as
in in tumors marked by acquired resistance to current therapy.

Public health relevance
Project Narrative The goal of this project is to develop new therapies for gastric and esophageal adenocarcinomas with amplification of the ERBB2 oncogene. We will specifically work to develop better pharmacologic strategies to stably inhibit ERBB2 in this lineage and to perform a prospective study in patients where we will define and then mechanistically validate the genomic alterations that promote resistance to current therapies targeting ERBB2.